Extreme heat events and fertility: a national study

PROJECT SUMMARY/ABSTRACT
The frequency and intensity of heatwaves and other extreme weather events is increasing rapidly owing to
climate change and is only projected to escalate in the coming decades. While the hazards of extreme heat on
human health are widely recognized, including adverse effects on pregnancy and birth outcomes, little is
known regarding ambient temperature and human fertility. Demographic studies suggest that hot weather
causes a significant decline in birth rates 8 to 10 months later, yet the drivers of this association are unclear.
The animal literature has also long documented a link between maternal hyperthermia induced by high
ambient temperatures and reduced fertility, largely mediated through effects on oocyte developmental
capacity; however, whether heat stress has a similar impact on follicular development in women is less clear.
The proposed research seeks to use a large existing database and robust methodological approaches to test
the overarching hypothesis that women exposed to extreme heat during folliculogenesis will have
compromised oocyte quality and embryo development, higher risk of implantation failure, and lower probability
of live birth. We also hypothesize that stronger effects will be observed following heat events of longer duration
and greater intensity and that effects will vary by temporal-, spatial-, and individual-level attributes. To test this
hypothesis, we will utilize data from over 2 million non-donor assisted reproductive technology (ART) cycles
initiated in the US from 1996 to 2016 that are collected as part of the National ART Surveillance System.
National weather data will be integrated using publicly available data from the High Resolution Land Data
Assimilation System– a national 1 km resolution dataset of near-surface temperature and humidity that spans
1981-2016. Women undergoing ART represent an ideal setting to investigate the hypothesis that extreme heat
affects fertility through adverse effects on the ovary as we can determine exact periods of extreme heat
exposure and directly observe early reproductive outcomes that would never be observed in couples
conceiving without assistance. By restricting our analysis to cycles using donor sperm and frozen embryo
transfers, we can also uniquely examine the effects of extreme heat exposure during folliculogenesis on ART
outcomes independent from heat exposures to the male partner and during the implantation window. Given the
parallel trends of rising temperatures and the increasing number of women delaying motherhood until 35 years
and older, understanding the effects of extreme heat on fertility is becoming increasingly important. Our
findings can greatly inform targeted regulations, policies, public health warning systems, and interventions with
the ultimate goal of reducing infertility and early pregnancy loss.

Public health relevance
PROJECT NARRATIVE The proposed research will investigate the effect of extreme heat events on fertility using couples undergoing assisted reproductive technology (ART) as a model of human reproduction. Using a large, nationwide study with over 21 years of follow-up, we will 1) evaluate the association between extreme heat and ART outcomes, 2) assess whether associations depend on the intensity, duration, and timing of extreme heat events, and 3) identify important individual- and community-level modifiers of this association which may confer increased vulnerability to heat. In Western countries where the average age at first birth is increasing, even a small effect of rising temperatures on human fertility could have negative consequences on birth rates and important implications for future population size and structure.